Open Data from the Exceptional Longevity Program

Abstract The NIA’s Exceptional Longevity (EL) program supports multiple consortia that are generating and analyzing data to better understand the biological mechanisms that underlie long life span. Given the high value and rarity of these data resources, the EL program is seeking to enable access to EL data to qualified researchers in order to promote transparency and to catalyze data reuse in a broad range of research. The AD Knowledge Portal (adknowledeportal.org) serves as an NIH designated repository to support the NIA’s strategic goal to propagate data sharing under FAIR principles and to promote open science. This project is focused on integrating the Exceptional Longevity program into the AD Knowledge Portal by distributing information on the program, designing the appropriate data governance strategy, and supporting the collection, management and dissemination of data and results from the EL program.

Public health relevance
Narrative Efforts to understand the aging process can help reveal the basis for complex diseases associated with aging, including dementias like Alzheimer’s disease (AD). The Exceptional Longevity (EL) program is aimed at identifying the biological correlates of exceptional long life. The EL program has generated highly valuable data and analytical results that will be made publicly available through the AD Knowledge Portal (adknowledgeportal.org) in order to accelerate the pace of aging research.